Rhode Island State Food Testing Laboratories Maintenance and Enhancement of ISO/IEC 17025 Accreditation

Project Summary / Abstract for State of Rhode Island Maintenance and Enhancement of ISO/IEC 17025 Accreditation and Whole Genome Sequencing for State Food Testing Laboratories Competition A Application Project Summary/Abstract The Rhode Island State Health Laboratories (SHL) is the state food regulatory laboratory accredited to the ISO/IEC 17025:2005 laboratory standards for the FDA Manufactured Food Regulatory Program (MFRPS) in support of the state and federal integrated food safety system under the Food Safety Modernization Act. The SHL seeks to enhance its food testing program and maintain its accreditation for both of its food microbiology and chemistry laboratories while transitioning to the updated ISO/IEC 17025:2017 laboratory standard. The SHL seeks to increase the number of samples collected and tested for the MFRPS program by utilizing its long standing partnership with the state’s food regulatory agency, the Center for Food Protection in the effort to improve the state’s sampling agreement for MFRPS. The SHL seeks to increase the laboratories’ capacity to provide standardized food testing for the FDA while it maintains conformance with Standard Ten of the MFRPS through training of its scientists and continually improving its systems. The SHL will communicate with regulatory laboratories in other states to gain insight into how they plan to sustain ISO 17025:2017 accreditation for food testing as it intends to achieve its own sustainability. The SHL intends to continue implementing the electronic formatting requirements as they evolve from FDA for eLEXNET. The SHL seeks to continue reporting all food sample test results to the FDA via the eLEXNET database. The SHL will continue its participation as a member of the Food Emergency Response Network (FERN) and a FDA Microbiology Cooperative Agreement Program (MCAP) laboratory.

Public health relevance
Project Narrative for State of Rhode Island Maintenance and Enhancement of ISO/IEC 17025 Accreditation and Whole Genome Sequencing for State Food Testing Laboratories Competition A Application Project Narrative The purpose of this project is to enhance and maintain ISO/IEC 17025 laboratory accreditation of the Rhode Island State Health Laboratories (SHL) serving as the primary food testing laboratory the FDA Manufactured Food Regulatory Program Standards (MFRPS) program in the state. During the project period SHL will update its accreditation to the new 2017 standard of ISO/IEC 17025 for laboratory accreditation. Through its sampling agreement with the state Center for Food Protection SHL will continue to build-up the state’s food testing laboratory capability and capacity to provide standardized food testing for the MFRPS to assure safety of the public food supply. In addition under its ISO/IEC 17025 accreditation SHL will continue to provide testing services to existing projects such as the FDA Microbiology Cooperative Agreement Program (MCAP) and as a Food Emergency Response Network (FERN) laboratory.